Administrative Core

SUMMARY- ADMINISTRATIVE CORE
The function of the Administrative Core is to manage the overall Program Project Grant (PPG) to maximize
resource deployment and ensure successful completion of the scientific objectives. The core oversees the
activities and broadly manages the budgets of the resource core and individual program projects, providing
organizational and logistical support as needed. In addition, a central role of the Administrative core is to act as
the communication hub of this program project by promoting and facilitating interaction amongst all PPG
components. Individual project PIs will have autonomy with regard to scientific planning and implementation at
the project level, but will be expected to incorporate suggestions from the Administrative and Scientific
Resource Cores and advisory committees. The Administrative Core will drive program integration at all levels
and embody the scientific mission of the PPG through an organized and well-implemented management
structure and research strategy.
The broad aims and central goals of the Administrative Core are:
1. Management: Manage overall program objectives and directions, and interactions between program
components; administer Resource Core usage; and oversee quality control, storage, and sharing of
primary data.
2. Communication: Communicate relevant and essential information to and facilitate interaction amongst
all PPG components, including formal and informal interaction with the Scientific Advisory Board (SAB),
including in-person and web-ex meetings, a seminar program, annual progress reports, yearly
symposia, and a dedicated program website.
3. Support: Provide over-arching organizational and logistical support (including financial management)
for all components of the PPG.
By providing PPG investigators with comprehensive program/project management support and facilitating
interaction among all personnel through multiple means, the Administrative Core augments the ability of the
PPG investigators to make substantive contributions to better understand melanoma biology.